DEVELOPMENT OF A NOVEL PEER RECOVERY SUPPORTER TRAINING PLATFORM TO DISSEMINATE EVIDENCE-BASED TRAINING AT SCALE

PROJECT SUMMARY/ABSTRACT
Thrive Digital Health (“TDH”) is developing a novel Peer Recovery Support Services (“PRSS”)
training platform (the “TDPP”) to standardize and scale the training of Peer Recovery Supporters.
TDH was founded by the principals of two successful existing companies at the forefront of
advancing PRSS, and benefits from the expertise of its CEO, who in addition to serving on the
board of the Peer Recovery Center of Excellence, is a nationally recognized thought leader on
PRSS training and implementation. The overarching goal of this Fasttrack project is to develop
and test an evidence-based platform that will extend standards-based and empirically-supported
Peer Recovery Support Services training and implementation across the country. Success in this
endeavor will expand access to support services for recovery from alcohol and other substance
use disorders, and help to address critical care gaps stemming from the treatment provider
shortage currently impacting the nation. We hypothesize that this scalable platform, used by
PRSS Trainers and Trainees, will be acceptable, feasible and usable, and will deliver a positive
effect in terms of knowledge gain, adherence and skill in Phase I. In Phase II of this Fasttrack
effort, we hypothesize that this platform will deliver superior training results among PRSS
trainees in terms of adherence and skill versus training-as-usual. Our priority commercial goal is
to bring this solution to market with organizations around the country seeking to build PRSS
capacity, and we will accomplish this through the following Phase II specific aims: (1) Assess the
effect on PRSS providers of the fully asynchronous TDPP and the TDPP with live zoom sessions
on skill and adherence compared with training-as-usual; (2) Assess the effect of adding three live,
interactive group teleconferencing sessions to the TDPP asynchronous content; (3) Conduct a
pre-post study with a pilot population of PRSS provider trainees from another state to assess
fidelity of implementation when content is localized for another state. The expected impact of
this project is to substantially enhance TDH’s ability to deliver effective PRSS training at scale,
expanding access to recovery support services across the country. This capability holds promise
to reduce negative health impacts at both an individual and societal level while reducing the total
cost of providing treatment services.

Public health relevance
PROJECT NARRATIVE Thrive Digital Health (TDH) is developing and testing a novel technology platform to enhance, standardize and scale the training of the Peer Recovery Supporter workforce. Peer Recovery Support Services are being increasingly implemented across the U.S. as a strategy to fill care gaps, and this platform will enable public and private organizations to efficiently and cost-effectively build their PRSS workforce, and support that workforce on an ongoing basis as they serve individuals recovering from alcohol and other substance use disorders. Over time, the innovations resulting from this project will significantly reduce costs for individuals, public and private payers, the healthcare system, and society at large.